Harnessing the EHR for the Delivery of Supportive Care in an Oncology Setting

Project Summary
Symptom management and supportive care are essential to high-quality cancer care and optimal patient
outcomes, but many barriers exist to their integration in routine oncology settings. Despite the availability and
cost-effectiveness of validated symptom assessment tools, evidence-based supportive care interventions and
clinical guidelines, adoption of supportive care using patient-reported outcomes in clinical practice remains low,
leaving many patients with poor symptom control, unmet needs, and preventable suffering. Patient-reported
outcomes offer one approach to symptom assessment by capturing the unique needs and values of each patient.
This strategy is effective in identifying patients' needs, but does not necessarily help oncology providers address
and manage these needs in their clinical interactions. Novel approaches are needed to facilitate systematic
symptom assessment and management, and guide the appropriate provision of supportive care in real-world
oncology settings.
To address this critical gap in cancer care, this project will involve the development and pilot testing of a
supportive care tool, embedded in the existing electronic health record, that collects patient-reported
assessments of symptoms and supportive care needs, using well-established tools, and links these data to a
system of evidence-based algorithms for supportive care. Specific aims of this project are: 1) to develop the
content, design and technical infrastructure of an EHR-integrated supportive care tool, based on a pre-
intervention assessment of stakeholder input and the local context; 2) to implement the EHR-integrated
supportive care tool over an [18-month] intervention period in 5 HNCP outpatient clinics, with potential exposure
of the tool to more than [300] eligible HNC patients and clinicians; and 3) to evaluate the [feasibility, acceptability,
and] initial implementation of the EHR-integrated supportive care tool using a mixed methods approach. Findings
from this project will provide the preliminary data to inform the design of a larger pragmatic randomized trial
across multiple cancer clinics.
The proposed K08 Career Development Award is designed to support the candidate's advanced training in
cancer care delivery research, with formal training in the fields of clinical informatics and implementation science,
while developing and pilot testing an electronic supportive care tool for use in routine oncology care. These broad
goals are consistent with the National Cancer Institute's mission and scientific priorities.

Public health relevance
Project Narrative With nearly 17 million cancer survivors living in the United States and 1.7 million new cancer diagnoses each year, effective delivery of supportive care to reduce symptom burden and promote quality of life in cancer patients is critical. There is strong evidence demonstrating the benefits of supportive care at all phases of cancer care, but unfortunately, many barriers exist to integration into routine cancer care, leaving many patients without adequate support for common physical and psychological symptoms. This project will develop and pilot test a novel tool within the electronic health record system to facilitate systematic symptom assessment and the tailored delivery of supportive care in a real-world multidisciplinary oncology setting.